Intranasal Insulin Administration as Medication for Alcohol Use Disorder

SUMMARY/ABSTRACT
While there have been developments in treatments for alcohol use disorder (AUD), current pharmacotherapies
face several limitations, including the presence of adverse events. Intranasal (IN) insulin has shown promise for
use in targeting addictive disorders. The overarching hypothesis of this proposal is based on the premise that IN
insulin by providing improvement of brain cell energy and glucose metabolism and stress hormone reduction,
may be an ideal approach for treating multiple domains of AUD including memory and impulsivity. Furthermore,
studies of IN insulin demonstrate that it is a safe and effective method for delivering insulin to the central nervous
system, circumventing the blood brain barrier and reducing adverse events (hypoglycemia). The main goal of
this proposed work is to tune up and test an integrated pharmacological, biobehavioral and clinical protocol to
test the safety/tolerability of IN insulin as a potential therapeutic for AUD. This is a Phase I/IIa, within-subject,
crossover, double-blind, placebo-controlled human laboratory study with an acute IN insulin (80IU) administration
compared to placebo in 40 non-treatment-seeking individuals with AUD. In Aim 1, we assess the safety,
tolerability and acceptability of IN insulin as pharmacological intervention for AUD. In Aim 2, we evaluate whether
there is a difference in adverse events between IN insulin and the placebo condition when co-administered with
alcohol. In Aim 3, we will evaluate whether IN insulin, compared to placebo, improves memory and reduce
impulsivity after the alcohol challenge. Finally, in Exploratory Aim, we will assess preliminary data on the effect
of IN insulin, compare to placebo on alcohol craving. The proposed research will generate: 1) the necessary
safety data and 2) the characterization of AUD patient endophenotype who may respond to IN insulin treatment.

Public health relevance
NARRATIVE Although many patients have benefited from existing medications for alcohol use disorder (AUD), their effects are moderate or not effective in some individuals. Future efforts in the development of medications for AUD need to include: establishing new targets for drug development; using validated animal models to test medications for AUD; and developing biomarkers to help predict drug response. In addition, if possible, it is important to utilize medications that are familiar within the clinical practitioner community which will facilitate the inclusion of these medications into the alcohol treatment process.